Administrative Core: Center for Diagnostic and Therapeutic Strategies in Pancreatic Cancer

Project Summary:
The administrative core will oversee the coordination of the "Center for Diagnostic and Therapeutic Strategies in
Pancreatic Cancer" (CDTSPC). It will provide essential resources to administer the organizational structure and
ensure the success of CDTSPC at North Dakota State University (NDSU). The Center will continue to develop
research programs led by Junior Investigators, promote biomedical translational research, enhance the research
infrastructure at NDSU, and provide enhanced mentoring to increase the number of NIH-funded research grants.
The goals of this Center are to develop self-sustaining research programs by Junior Investigators, increase the
number of NIH-funded researchers, and expand the University's research capability on a disease-specific
program, particularly in pancreatic cancer. These goals will be accomplished through the following Specific
Aims. Aim 1: Continue to provide efficient leadership and administrative structure for the successful operations
of CDTSPC. The Administrative Core will ensure that the Junior Investigators are supported by all Core Facilities
and equipment needed to ensure rapid research progress. The Center will conduct formative and summative
assessments of all projects, Core Facilities, and the career development-mentoring plan. In addition, the
Administrative Core will be responsible for budget management, External Advisory Committee (EAC) meetings,
symposia, and yearly reports to NIGMS. Aim 2: Implement an enhanced, result-oriented, multi-tier mentoring
strategy to accelerate the career development of the Junior Investigators. The Administrative Core will implement
an enhanced mentoring model that identifies two external and one internal mentor and one peer advisor
(mentoring team) for each Junior Investigator. The mentoring team will address future research directions,
organization and presentation of manuscripts, strategies for writing competitive proposals, and proposal review
before submission. Furthermore, Junior Investigators will engage with CDTSPC's Translational Science Liaison
and receive mentoring on the translational aspects of their projects. Aim 3: Enhance biomedical research
infrastructure at NDSU. The Administrative Core will competitively recruit a replacement once a Junior
Investigator graduates as an independent investigator through a campus-wide proposal solicitation, external
peer review, recommendation of the EAC, followed by NIH approval. Aim 4: Accomplish the self-sustaining
status of CDTSPC. All investigators will compete for extramural research grants from federal and non-federal
resources in the competitive field of cancer biology. In addition, the Administrative core will ensure timely
completion of the CDTSPC milestones.

Public health relevance
Project Narrative: The proposed “Center for Diagnostic and Therapeutic Strategies in Pancreatic Cancer” in North Dakota State University will continue to support foundational and translational studies devoted to controlling pancreatic cancer at cellular and animal model levels. The Administrative Core will serve as the organizational point of contact for all components of the Center. The Center will enhance the biomedical research infrastructure of the university. The Administrative Core of the Center will facilitate and ensure that all the components of the Center are functioning efficiently and successfully. __________________________________________________________________________________________